Short Chain PFAS Adsorption via AimmSorb

PROJECT SUMMARY
Per- and polyfluoroalkyl substances (PFAS, typically called “forever chemicals”) are a family of over 9,200
chemicals with research indicating a link between exposure to PFAS and various adverse human health
outcomes. PFAS is a HUGE problem, estimated to be found in the blood of 97% of Americans. Traditional PFAS
used were PFOA and PFOS and could be removed from water via two primary water treatment options: activated
carbon (AC) and resins. These two PFAS were generally phased out once their hazardous nature was
discovered and they were replaced by shorter PFAS. These shorter PFAS (named short chain—SC, or ultra
short chain—USC) are more difficult to remove from the water than their longer chained counterparts. This makes
current treatment methods of AC and resins much less effective at removing them. Thus, new approaches must
be found that are more effective. In this study AIMM will continue to optimize our proprietary, patent pending
innovation, AimmSorb, to maximize the effective PFAS capture range, speed and length of use. This proposed
work will enable carbons to be specifically tuned to target PFAS-- improving PFAS removal speed, the ability to
remove long chain, SC and USC PFAS and demonstrating the ability of AIMM’s materials to be
reused/regenerated--all verified as commercial pain points through AIMM’s customer discovery. Testing will be
conducted to evaluate the adsorption performance for traditional longer chain, SC and USC PFAS. Verification
of AimmSorb as a reusable sorbent via thermal regeneration will also be conducted. Targets for ideal
temperature and dwell time will be used that are of interest to industry and have been demonstrated to be viable
through experience and the literature. The heart of the AimmSorb innovation, is a carbon powder, as is AC, and
therefore compatible with established AC water treatment engineering and processing routes and filter forms
that are already being used. This aids in ease of commercialization and customer familiarity while performing at
a much more successful level than current filters. AIMM plans to use the successful results of the proposed
Phase I work to serve as a foundation for a Phase II effort centered around the eventual fabrication of
commercial-ready PFAS treatment systems.

Public health relevance
PROJECT NARRATIVE Per- and polyfluoroalkyl substances (PFASs) have been shown to have negative impacts on human health and be in almost everyone’s bloodstream. In this study AIMM will continue to modify our proprietary, patent pending innovation to improve PFAS removal in several ways: increased removal speed, increased range of PFAS removal to include short chain and ultra short chain PFAS as well as the traditional long chain PFAS and demonstrate the ability of AIMM’s materials to be reused/regenerated. This work will lead to the eventual fabrication of improved commercial-ready PFAS treatment systems.